Mechanism and Anti-Cancer Activity of SCFA-Hexosamine Analogs

Pancreatic cancer remains almost incurable and has recently surpassed breast cancer as the third leading
cause of death from malignant disease in the United States; an estimated 53,070 Americans will be diagnosed
with pancreatic cancer and 41,780 will die from the disease this year (statistics from the Pancreatic Cancer
Action Network). This project builds on two metabolic glycoengineering (MGE) approaches that our group has
developed in previous funding periods for the parent R01 grant that reverse the disease-driving impact of two
types of abnormal glycosylation broadly associated with cancer. One approach exploits our “high flux” ManNAc
analogs that increase sialylation, which masks galectin binding sites on highly-branched N-glycans and thereby
attenuates “galectin lattice” strength and reduces multiple aspects of cancer progression (our work focuses on
EGFR but surveys a range of additional oncogenic surface markers). This approach will test the non-natural
azide-modified form of ManNAc as a step towards developing theranostic treatment options where the sugar
analog not only sensitizes drug resistant cancer cells to tyrosine kinase inhibitors (TKIs) but can also be used
to image cancer using “click chemistry” probes. In a complementary approach, we will use an alternative
strategy to reduce cancer-driving glycosylation by inhibiting metabolic flux through the hexosamine biosynthetic
pathway (HBP), which prevents the initial formation of the galectin lattice as well as knocking down other
oncogenic glycoforms (for example, the “O-GlcNAc” protein modification). This project will compare each of
these approaches in cell lines that provide genetic diversity found in human patients (our expectation is that
our “glyco” approach will transcend genetic diversity and be broadly applicable) and then demonstrate efficacy
in rodent models of pancreatic cancer using patient-derived cells and xenografts available to our team through
the Johns Hopkins Medical Institute’s Division of Gastrointestinal and Liver Pathology (Dr. Anne Le, the co-
investigator on this project is a faculty member of this division and has several years of experience conducting
research with cell- and xenograft models of pancreatic cancer).

Public health relevance
Pancreatic cancer remains almost incurable with less than a 2% 5-year survival rate for cases that are diagnosed at a late stage (which most are); overall this type of cancer has recently surpassed breast cancer as the 3rd most prevalent source of mortality from this disease. This project builds on our previous work where we showed that “metabolic glycoengineering” can overcome drug-resistance in advanced stage pancreatic cancer cells. In the current grant period, we intend to demonstrate that this desirable feature holds across genetically diverse cases of pancreatic cancer and show that our therapeutic approach is viable in animal models as a prelude to clinical translation.